Continuously Variable Protein Delivery Using a Photoactivated Depot

Project Summary
The administration of drugs like insulin requires continuously variable delivery. This is because
blood glucose is itself continuously varying, and the insulin requirement parallels the amount of
glucose in the blood. The only clinically used method to permit continuously variable deliver of
therapeutic proteins like insulin is a pump. Pumps can vary therapeutic delivery but they do so at a
high cost: a physical connection of the outside of the patient, where the drug reservoir resides, and
the inside of the patient, where drug absorption will ultimately take place. This connection in the
case of insulin pumps is a cannula or needle, which can be dislodged, crimped, snagged, infected and
most importantly, rapidly gets biofouled after implantation. This leads to variable and unpredictable
delivery. Instead, we are developing the Photoactivated Depot or PAD approach and applying it to
insulin use. With the PAD approach, an insulin containing material is injected into the skin, just like
regular insulin, but remains there inactive until a light source that is outside the body stimulates the
injected material through the skin with light to release insulin. Our first generation PAD designs
linked insulin to a polymer via a light-cleaved linker. When a pulse of light from an LED illuminates
this material, insulin is released, and the amount released is proportional to the amount of light. We
have demonstrated that these materials work in diabetic animals to release insulin and reduce blood
glucose. Despite this success, these first generation materials have performance that makes them
untenable for human use. Specifically, the linked polymer that is used to insure that insulin stays at
the site of injection makes up >90% of the material, meaning that the total insulin present is less than
what is needed for human efficacy. In addition, the low density of insulin means that the rate of
photo-cleavage is also insufficient. Because of this, we are proposing multiple approaches to address
these issues. In Specific Aim 1 we are creating multiple new PAD materials that eliminate the polymer
required in our first generation materials, and in so doing create much higher density materials that
are 90% insulin. In Specific Aim 2 we are incorporating new light-cleaved linkers that will release
insulin using higher wavelengths of light. This will increase the amount of light that reaches the
depot, and hence the ease of insulin release, because longer wavelengths of light penetrate tissues
more easily. Finally, in Specific Aim 3 we are closely examining these new materials for their ability to
control blood glucose in diabetic animals. By executing these three aims, we anticipate creating a
new and revolutionary approach to continuously variable protein delivery, one that minimizes
invasiveness, and maximizes the close matching of therapeutic with patient requirements.

Relevance

The successful completion of the proposed work will create a new method to administer insulin that
effectively eliminates most of the injections normally required or the need of a pump and reduces
variations in blood sugar. This has the potential to improve both the quality of life and the quality of
health of diabetics who depend on insulin to live.

Public health relevance
Project Narrative We propose to create optimal materials that allow for insulin delivery to be controlled by light. By doing so, we will eliminate the need for insulin pumps and enable the creation of a minimally invasive artificial pancreas.